Administrative Core

Administrative Core - Abstract
The Administrative Core will coordinate all activities of the Nevada INBRE with direct responsibility for
compliance, fiscal management, facilitating communication in the network, oversight of all research activities,
coordination of training and mentoring, coordination of pipeline programs, and tracking and evaluation. The
Administrative Core will link the network institutions to the Data Science Core for Biomedical Research,
research opportunities and service award opportunities with scientific cores statewide. The Administrative
Core will coordinate a statewide Developmental Research Project Program and facilitate student programs at
partner institutions and Primarily Undergraduate Institutions (PUI’s). The Administrative Core will increase
research investigating Cell Growth and Differentiation by uniting students, teaching faculty, and research
faculty statewide in collaborative research and training.